COUNTERREGULATION OF INSULIN'S ACTION BY CATECHOLAMINES

The interaction between catecholamines and insulin in regulating glucose transport in isolated rat adipose cells has been evaluated. The initial results suggest that catecholamines counterregulate insulin-stimulated glucose transport in rat adipose cells through a cAMP-mediated mechanism, but only in part by modulating the translocation of glucose transporters. The mechanism of the counterregulatory effects of lipolytic and antilipolytic hormones on insulin-stimulated 3-0-methylglucose transport in rat adipose cells has been further investigated under the stringent incubation conditions described by Londos et al. (Adv. Cyc. Nuc. Res. 17) that maintain steady state A-kinase activity ratios (plus/minus cAMP), a measure of cAMP concentration. Under these conditions, lipolytic and antilipolytic hormones counterregulate insulin stimulated glucose transport activity through a cAMP-independent modulation of glucose transporter intrinsic activity and a marked change in sensitivity to insulin apparently occurring at the level of the signaling mechanism.